Role of obesity in blood pressure regulation and insulin resistance in Polycystic Ovary Syndrome

Polycystic Ovary Syndrome (PCOS) is the most common endocrine disorder in reproductive-age women. PCOS
is diagnosed by elevated androgens, ovulatory dysfunction, and polycystic ovaries. Women with PCOS have a
high prevalence of cardiovascular risk factors (CRFs), such as obesity, insulin resistance (IR), and elevated
blood pressure (BP). Effective therapeutic agents to treat CRFs found in PCOS women are limited. The long-
term goal is to find effective and safe therapeutic agents to treat CRFs in PCOS women. The Renin-Angiotensin
System (RAS), with its classical and nonclassical pathways, is a regulatory system for BP control and metabolic
function. The adipose tissue has a fully functional RAS with systemic, paracrine, and autocrine actions. This
research proposal will elucidate the role that the adipose classical and nonclassical RAS plays in IR and BP
regulation in PCOS. IR is present in lean and obese PCOS women. Plasma adiponectin levels, an insulin-
sensitizing hormone, are low in PCOS women, making it an attractive molecular target to decrease IR. The goal
of this proposal is to study the interplay between androgens, adiposity, adipose classical and nonclassical RAS,
and adiponectin to mediate CRFs in PCOS women. Our central hypothesis is that “hyperandrogenemia has
obesity-dependent and -independent effects, leading to increased BP and IR in PCOS. Activation of the classical
and inactivation of the nonclassical adipose RAS lead to increased BP. Furthermore, independent of obesity,
androgens cause IR via decreased adiponectin levels in PCOS”. This novel and clinically relevant hypothesis
will be tested with these aims: Aim 1: To test the hypothesis that obesity as a result of hyperandrogenemia
causes an activation of the RAS and increases BP in the PCOS model; Aim 2: To test the hypothesis that an
imbalance of the adipose classical and nonclassical RAS in response to hyperandrogenemia leads to increased
BP in the PCOS model; Aim 3: To test the hypothesis that decreases in adiponectin in response to
hyperandrogenemia lead to obesity-independent IR in the PCOS model. We will test this hypothesis using an
innovative combination of gold-standard methods to measure BP, IR, fat distribution and function, and
systemic and adipose RAS peptides in two well-characterized, clinically relevant models of PCOS and a 3D
adipocytes cell culture. The proposed research is significant because it will shed light on the androgens-
mediated mechanisms and the interplay between obesity, the classical and nonclassical RAS, and adipokines
in the pathophysiology of the CRFs in PCOS women. Moreover, this study will identify potential new therapeutic
options to ameliorate CRFs in PCOS women.

Public health relevance
Polycystic ovary syndrome (PCOS) is a common health condition that affects about 10% of women of reproductive age. Women with PCOS have elevated levels of the male androgen hormone testosterone and a high prevalence of obesity, insulin resistance, and elevated blood pressure, which lead to cardiovascular disease. This proposed research will shed light on novel androgens-mediated mechanisms that will translate into effective and safe therapeutic agents to treat the cardio-metabolic complications frequently found in women with PCOS.